Development of highly potent human monoclonal for RSV immuno-prophylaxis

PROJECT SUMMARY
Respiratory syncytial virus (RSV) is a leading cause of infant hospitalizations in the U.S., and the disease
burden among the elderly is similar to non-pandemic influenza A. Traditional strategies have failed to generate
an effective RSV vaccine, and in some instances vaccination resulted in enhanced disease, underscoring the
complexity of the human immune response to RSV. Although a prophylactic antibody is available (palivizumab,
a humanized mouse mAb marketed by MedImmune as Synagis®), its high cost and modest efficacy have
restricted its use to high-risk infants. Moreover, due to this high cost, palivizumab is inaccessible to children in
developing nations and is unavailable in 4 of the 5 most populous countries – more than half the world’s
population does not have access to this type of treatment.
The public health benefit and the worldwide accessibility would undoubtedly be improved by lowering the cost
of RSV immunoprophylaxis. In this Phase 2 proposal, the University of Texas at Austin, Adimab (Lebanon,
NH), Einstein College of Medicine (The Bronx, NY) and Mapp Biopharmaceutical, Inc. (San Diego, CA),
teamed to develop a fully human, highly potent mAb that can be administered in a single dose per RSV
season. With a more potent mAb (i.e. lower dose) that can be dosed less frequently (due to extended serum
half-life), the team’s objective is to dramatically lower the price and increase the availability of RSV
immunoprophylaxis. In addition, competition in the marketplace may also help to reduce costs and increase
accessibility globally, especially since palivizumab currently has a monopoly on the RSV market. Our Phase 1
effort identified 3 lead candidates (from a panel of 445 mAbs), all of which are dramatically more potent in vitro
and in vivo than palivizumab. Further, these mAbs have similar neutralization activity to AstraZeneca’s second
generation RSV mAb MEDI8897 (currently in late stage clinical development) against the 5 RSV strains tested
to date. After the success of these Phase 1 efforts, we propose the following Specific Aims for Phase 2: 1)
Select a lead candidate based on breadth and potency of neutralization activity against a panel of clinical
isolates; 2) Generate a CHO cell line appropriate for GMP manufacture; 3) Manufacture for IND-enabling
studies; 4) Conduct IND-enabling studies.

Public health relevance
PROJECT NARRATIVE Respiratory Syncytial Virus (RSV) infects nearly all children by 2 years of age. In the U.S., RSV is the leading cause of lower respiratory tract disease in young children and a major cause of asthma and wheezing throughout childhood. RSV has a disease burden similar to that of non-pandemic influenza A for elderly (>65 years of age) and high-risk adults (congestive heart failure or chronic pulmonary disease). Our long-term goal is to develop a safe and effective immunoprophylaxis product for RSV. In addition to infant populations, use of the product in elderly populations may provide protection in nursing homes and rehabilitation hospitals during the RSV season.